Characterizing and manipulating large-scale activity in the brain

Intrinsic brain activity exhibits time-varying, non-localized states which are altered in psychiatric and
neurological disorders. Intrinsic activity is dominated by a few whole-brain spatiotemporal patterns that occur
repeatedly over time (quasiperiodic patterns or QPPs). In particular, research has linked QPPs to attention and
focus, traits that are affected by disorders such as attention deficit/hyperactivity disorder (ADHD) and major
depressive disorder (MDD). However, QPPs are whole-brain phenomena detected with functional magnetic
resonance imaging (fMRI), which makes them difficult to interpret in terms of underlying neural activity. Hints of
similar repeated spatiotemporal patterns have been observed in wide field optical imaging (WOI), which can
image neural activity directly. We hypothesize that QPPs are surrogates for faster repeated patterns of neural
activity detected with WOI, and that behaviorally-relevant brain states can be defined by the relative incidence
of a few QPPs.
The observation that large-scale dynamics of intrinsic brain activity are altered in psychiatric and neurological
disorders suggests that interventions that reverse these alterations and restore normal whole-brain dynamics
may prove therapeutic. We will therefore attempt to purposefully affect the relative expression of QPPs and
underlying neural brain states as a demonstration that they can be manipulated in a predictable manner.
Based on our prior work, we hypothesize that a multisensory flicker, a strong sensory stimulus, can alter the
relative expression of QPPs.
We will test these hypotheses using a state-of-the-art method for simultaneous WOI of fluorescent calcium
indicators and whole-brain fMRI in unanesthetized mice. Specific aims are 1) Use simultaneous WOI and
fMRI to determine whether the distribution of QPPs reflects underlying patterns of neural activity
during behaviorally-relevant states and 2) Determine whether multisensory stimulation can alter the
expression of WOI neural patterns and fMRI QPPs.
Fluctuations in mood, focus, arousal levels, etc, are universal in healthy humans and often symptomatically
affected in mental disorders. These attributes vary on relatively slow time scales and are likely to arise from
systems-level brain states rather than localized changes in neural activity. We anticipate that the relative
expression of a few spatiotemporal patterns will be sufficient to characterize natural changes in brain state over
the course of a scan, in this case produced spontaneously by a shift from quiescence to activity or deliberately
by the application of sensory stimulation. Because QPPs can be detected noninvasively in healthy humans, if
they prove adequate as a surrogate for whole-brain configurations of neural activity, they will be valuable for
characterizing brain states related to mental attributes and their alteration in disorders. They may also serve as
guides for the design of modulatory approaches and markers of successful intervention.

Public health relevance
PROJECT NARRATIVE The intrinsic or ‘background’ activity of the brain is essential for normal function and influences perception, behavior and cognition. We will apply innovative multi-modal imaging techniques to characterize patterns of neural activity related to different brain states and behaviors, then attempt to alter brain states using sensory input. Patterns of intrinsic activity are affected in nearly every psychiatric and neurological disorder, and the work we propose will help us to understand these patterns for the purposes of diagnosis and evaluation, and how they might be manipulated for therapeutic effects.